Integrative Training in Oncogenic Signaling

PROJECT SUMMARY/ABSTRACT
This first renewal application seeks continued National Cancer Institute (NCI) support for a successful ‘Integrative
Training in Oncogenic Signaling’ (ITOS) Program developed to train postdoctoral fellows by a select group of
cancer scientists affiliated with the Hollings Cancer Center (HCC) at the Medical University of South Carolina
(MUSC). The programtakes place in an active and growing medical center with state -of-the-art facilities,a vibrant
NCI-designated cancer center, and an active Office of Postdoctoral Affairs. Led by a Program Directorship team
with an exceptionally strong cancer research and leadership background, the ITOS Program selects and
supports the placement of trainees in experienced, well-funded, productive laboratories led by the Program
Faculty who reside in an interactive, multi-departmental research environment with extensive resources. Each
trainee has a primary mentor and one/two secondary mentors with complementary expertise to ensure distinct
and valuable perspectives that enhances the overall cancer-relatedresearch training experience. The objectives
of the ITOS Programremain unchanged, seeking to provideproactive mentoring, oversight and research training
in cutting-edge methodology; to develop useful academic and essential career development skills; to foster
collaborative, interdisciplinary interactions with faculty and other trainees; and, to provide exposure to current
cancer research discoveries and how these are being translated into novel approaches to prevent, diagnosis,
and treat cancer. The ITOS Program has seven essential programmatic components: 1) 33 member Program
Faculty who share common cancer research interests and provide essential mentoring for trainees; 2) one to
two year experiences in designated Program Faculty laboratories; 3) an ITOS Program Research Club providing
an engaging community forum for the trainees and Program Faculty to discuss work in progress as well as the
latest discoveries; 4) shared research resource workshops and tailored training in cutting-edge biotechnologies;
5) interdisciplinary engagement with trainees in HCC-sponsored thematic research retreats, symposia, work in
progress meetings, and seminars; 6) career development workshops and courses that equip trainees for
independent success; and, 7) opportunities to network nationally at a minimum of two professional conferences
each year. In its fourth year, the ITOS Program has graduated 9 fellows; 1MD, 1MD/PhD, 7 PhDs. Trainees from
diverse backgrounds, 58% female and 30.8% underrepresented racial/ethnic minorities, whom have all
successfully transitioned to positions in academia or industry. Based on the capabilities, capacity, trajectory of
MUSC for cancer-related training, and the successful accomplishments achieved during its initial funding period,
the ITOS Program is requesting the support for seven postdoctoral trainees each year, representing an increase
of two trainee positions. In summary, our ITOS Program offers distinct experiences and opportunities only
afforded to the selected ITOS Fellows, and the program, led by an outstanding cadre of Program Faculty, is
anticipated to remain highly attractive to emerging junior investigators locally and nationally.

Public health relevance
PROJECT NARRATIVE Despite the tremendous progress that has been achieved in understanding the complex biology of cancer over the past several decades, it remains a major health care challenge and requires a highly trained work force to continue to develop new, more effective therapeutic approaches. The Hollings Cancer Center at the Medical University of South Carolina seeks continued funding for its Integrative Training in Oncogenic Signaling (ITOS) Program. This Program is led by a specialized group of core scientists who provide a structured, integrated training experience to ensure the next generation is equipped with contemporary, interdisciplinary approaches and technical expertise that will eventually overcome the challenges to this disease.